Manipulating DNA Damage-response Signaling for the Treatment of Type 1 Diabetes

Abstract
Type 1 diabetes (T1D) is a common autoimmune disease in children and young adults. T1D presents
as acute onset hyperglycemia resulting from the immune-mediated destruction of insulin-producing pancreatic
beta cells. The central pathogenic driver of T1D is the beta cell antigen-specific (ag.-sp.) T cell. There is no durable
cure for T1D; the sole and costly treatment for T1D remains daily insulin replacement. Even with vigilant glucose
monitoring and control, T1D patients still suffer a host of life-threatening sequalae including macro- and micro-
vasculopathies, neuropathy, nephropathy, amputations, stroke, and blindness. While progress has been made in
(i) producing and delivering insulin, (ii) monitoring blood glucose, (iii) identifying autoantigens, (iv) defining
genetic risk factors, (v) understanding underlying immune dysfunction, and (vi) producing and harvesting
pancreatic islet cells for transplant, the most intractable barrier remains our inability to remove or control islet
ag.-sp. T cells, without which the promise of preventing/curing T1D will likely fail.
To surmount this critical barrier, we devised the means to eliminate diabetogenic T cells from
the adaptive immune repertoire. In fact, when applied to non-obese diabetic (NOD) mice with spontaneous
new-onset T1D, we observe (i) a striking prolongation of the remission or “honeymoon” period, (ii) a significant
reduction in beta cell-specific CD4+ and CD8+ T cells, (iii) a significant preservation of beta cells, and (iv) a highly
significant reduction (78%) in the number of NOD mice that transit to overt diabetes.
The premise: As T cells toggle between distinct states – naïve, activated effector, quiescent and activated
memory – they exhibit ineluctable properties that we can precisely target. This is particularly true of activated
effector CD4+ and CD8+ T cells (Teff). Unlike their counterparts, Teff cells divide rapidly – at a rate of once every
5-6 hours in vivo – and exhibit an intrinsic DNA damage response (DDR) that places them on the edge of
apoptotic cell death. We hypothesize (i) that this unique aspect of lymphocyte biology lead to genomic stress
in acutely activated lymphocytes and (ii) that manipulation of DDR signaling pathways allows for selective
therapeutic targeting of pathological T cells. Consistent with these hypotheses, we find that both mouse and
human Teff cells display a pronounced DDR, as evidenced by DNA damage, phospho-ser139 H2AX (γH2AX),
and phosphorylation of ATM, CHK2, and p53. Moreover, we find that novel drugs that potentiate p53 (via
inhibition of MDM2) or impair cell cycle checkpoints (via inhibition of CHK1/2 or WEE1) lead to the selective
elimination of pathological Teff cells in vivo when given during a prescribed therapeutic window. In combination
of these compounds – which we termed “p53 potentiation with checkpoint abrogation” (PPCA) – display clear
therapeutic benefit, targeting pathological T cells but does not naive, regulatory, or quiescent memory T-cell
pools, and has a modest nonimmune toxicity profile. These results, recently published, (PNAS 2017,
PMC5474825) suggest a novel and tractable clinical strategy for a highly selective form of immune therapy that
is (i) specific for both CD4+ and CD8+ auto-reactive Teff cells, (ii) minimally or non-genotoxic, and (iii)
markedly better tolerated than current approaches. Importantly, this approach does not alter tissue-resident
Treg cell numbers; in fact, our data suggest that PPCA resets the regulatory balance in favor of Treg control of
anti-beta cell immunity.
Based on our preliminary and published data, we propose three inter-related hypotheses: (i) that
PPCA has a distinct mechanism of action that eliminates Teff cells while sparing Treg cells, thereby re-
establishing a localized regulatory balance; (ii) that PPCA can target the control of both auto- and allogeneic T
cells, thereby allowing for sustained transplantation tolerance to islets, and (iii) that PPCA can preferentially
target islet ag.-sp. activated human T cells in individuals with T1D while sparing the memory compartment.

Public health relevance
Project Narrative Type I diabetes is caused by an aggressive population of lymphocytes that selectively recognize and destroy the pancreatic cells that produce insulin. We have found a novel therapy that takes advantage of a unique state acquired by activated lymphocytes when they are attacking insulin producing cells. Our experiments show that we can target lymphocytes in this state using drugs that have been developed by the cancer field. Importantly, we found these drugs to be useful in significantly reducing diabetes incidence in mice that have already shown signs of disease. Strikingly, unlike current medications that globally suppress immune responses, these drugs appear to not affect other lymphocyte populations and therefore retain vaccine-induced immunity and the ability to fight new infections. While these drugs show significant promise, we have proposed here to better understand the underlying molecular mechanism of action of these drugs and how that target immune cells that cause type 1 diabetes but spare regulatory cells beneficial to the immune system. In addition, we will investigate the role of this therapeutic approach with respect to islet transplantation and in samples from human T1D patients.